Addressing the paradox of poor outcomes despite successful recanalization in stroke

Project Summary
In recent years, endovascular stroke therapy (EVT) has emerged as a highly effective treatment for large vessel
occlusions (LVO) acute ischemic stroke (AIS). However, while our ability to achieve recanalization in these
patients is exceeding 90%, still over 50% of these patients are left with moderate to severe disability. In this
project we propose a novel classification for this under-studied population, which categorizes these patients
based on etiology of persistent dysfunction. We hope to generate an improved understanding of this gap between
successful recanalization and good clinical outcomes, to identify the cohort of patients in whom additional
measures may be necessary, and to create a machine-learning (ML) tool that will implement this improved
understanding as clinical decision support tool. To do this, we propose the following Aims:
Aim 1: We will create a longitudinal clinical and imaging dataset and evaluate more completely the role of final
infarct volume (FIV) on outcome. We will create a multi-center dataset including imaging and clinical data from
3 large hospital systems across the US, with pre-procedure and follow up imaging at 24-48 hour and 5-14 day
time points in patients with LVO AIS treated with EVT. We will then use infarct volume and location information
from early and late follow up MRIs to predict likelihood of good outcome from FIV data.
Aim 2: We propose, derive, and validate a novel classification system for patients with disability despite
reperfusion and generate machine learning models to identify them based on data obtained prior to EVT. The
model will be trained using clinical and imaging data and tested in independent cohorts, which will be drawn from
multiple hospitals to better represent a diverse population.
Aim 3: We will create deep learning models using raw patient-level cross-sectional and angiographic imaging
data to identify patients with persistent disability despite reperfusion, and their subtypes. We will leverage our
longitudinal-sensitive deep learning models to learn from the change between pre- and immediate post-EVT with
imaging and clinical variables to predict clinical outcomes in patients treated with EVT.
Completion of these aims will provide a means to characterize and identify patients with poor clinical outcomes
despite successful recanalization. These results will establish the foundation for future clinical trials by
discovering which clinical and/or imaging features are key drivers of clinical outcomes. We will provide a positive
impact by creating a simple, universally accessible method to identify the most vulnerable patients who may
need additional treatments beyond EVT for LVO AIS.

Public health relevance
Project Narrative With endovascular stroke therapy, we now can rapidly recanalize the occluded vessel that is causing stroke; however, only about half the patients that receive this treatment have a good neurological outcome. The goal of our proposal is to better understand this population that does not benefit by organizing them into different categories based on etiology of their persistent dysfunction. We will then generate models that use machine learning to predict who those patients might be, so that we could target treatments specific to the etiology of their dysfunction.